A home-based intervention to promote mindful breathing awareness through pursed-lip breathing training for COPD patients

Project Summary/Abstract
MHS proposes the development of a system to guide patients with chronic obstructive pulmonary disease
(COPD) to complete a mindful breathing practice at home. COPD is the third leading cause of death in the United
States and no cure exists. Shortness of breath is the most common disabling symptom. Mindful pursed lips
breathing is a type of breathing practice that has demonstrated effectiveness for patients with COPD. It requires
practice to maintain and there is currently no home system to provide the needed feedback and support to
maintain PLB. Additionally, syncing breathing and heart rate variation offers patients additional benefits. The
proposed project explores the addition of a mindful breathing module to an already effective and developed
home based rehabilitation program to guide COPD patients in a mindful breathing practice and further palliate
breathlessness and anxiety.

Public health relevance
Project Narrative COPD is a progressive lung disease that makes breathing difficult. COPD usually worsens over time and eventually may make it difficult for people to carry out regular, simple daily activities, such as walking or taking care of oneself. It is estimated that the direct costs of COPD in the United States are $29.5 billion and the indirect costs are $20.4 billion. A mindful pursed-lips breathing practice is an an established treatment for COPD that improves breathlessness and anxiety. We propose to add a novel module to motivate and monitor patients with COPD to establish an effective mindful breathing practice to an effective program for home pulmonary rehabilitation.